Prenatal Extracellular Vesicles and Steroid Hormones as Biological Mechanisms Underlying Gestational Factors Associated with Neurodevelopmental Risk

Project Summary/Abstract
The applicant's career goal is to lead a multidisciplinary research program that will investigate a network of
perinatal pathways through which maternal, fetal, and placental physiology impacts fetal brain development
and risk for neurodevelopmental disorders, including autism spectrum disorder (ASD). The research will
implement translational and clinical research approaches to uncover early-emerging biomarkers that may
serve as tools for early identification of at-risk children. To effectively establish and lead this research program,
intensive training in longitudinal study design, molecular biology, endocrinology, clinical psychology/psychiatry,
and statistics is required. The K99 study aims to address a crucial gap by evaluating the independent and
interactive effects of prenatal maternal/fetal EVs and maternal/fetal steroid hormones as potential biological
mechanisms underlying infant neurobehavioral and social-emotional development. Postnatally, elevated EV-
associated protein (EV-AP) levels and upregulation of EV microRNAs (miRNAs) have been observed in
individuals with neuropsychiatric conditions including ASD. However, no prior studies have evaluated the
relationship between prenatal maternal/fetal EV-AP levels and later child neurodevelopment. It has also been
shown that higher levels of the Δ4 steroid hormones (progesterone, 17α-hydroxy-progesterone,
androstenedione and testosterone) in amniotic fluid are associated with greater ASD-related behaviors.
Therefore, aberrant levels of both EVs and steroid hormones have been implicated in ASD pathophysiology.
The proposed K99 study will use biological data (maternal/fetal EVs, maternal/fetal steroid hormones) and data
obtained through neurodevelopmental assessments as part of a large, longitudinal pregnancy cohort study to
determine the interactive effect of elevated EV-AP levels and elevated levels of the Δ4 steroids on infant
neurobehavioral and social-emotional development. Elevated levels of EV-AP and Δ4 steroid hormones have
also been observed in women diagnosed with a hypertensive disorder of pregnancy or gestational diabetes
mellitus, conditions that are associated with increased neurodevelopmental risk in offspring, suggesting that
these biological mechanisms may mediate the neurodevelopment risk associated with these gestational
conditions. The R00 study will involve a moderated mediation analysis to evaluate whether the level of EV-APs
and Δ4 steroids contributes to the observed association between hypertensive disorders of
pregnancy/gestational diabetes mellitus and offspring neurobehavioral and social-emotional development. This
approach will elucidate new biological mechanisms underlying neurobehavioral development and may provide
important tools to identify children in need of early intervention services.

Public health relevance
Project Narrative This K99/R00 Pathway to Independence Award seeks to provide training in the design and management of longitudinal pregnancy cohort studies, advanced biostatistics, and the measurement and interpretation of extracellular vesicles, steroid hormones, and infant and toddler neurodevelopmental outcomes under a Developmental Origins of Health and Disease (DOHaD) framework to support the applicant's transition to research independence. Through the training plan, the applicant will develop the skills and expertise necessary to establish a translational research program that will examine a network of perinatal pathways through which maternal, fetal, and placental physiology impacts child neurodevelopmental outcomes, including risk for ASD. This approach may reveal new biological mechanisms underlying neurodevelopmental risk and may provide early-emerging biological markers, which are critical for identifying children in need of early intervention.